Investigating the role of SHP2-PLCG1 interaction in PDAC calcium signaling and metabolism

ABSTRACT
Pancreatic Ductal Adenocarcinoma (PDAC) is a highly lethal disease and is expected to become the second
leading cause of cancer-associated-death in the US by the year 2025. Of these cases, greater than 90% of
patients harbor a mutation to KRAS. Unfortunately, direct targeting of the mutations specific to PDAC have failed
to gain traction, but due to mutant KRAS’s ubiquity to the disease, alternative methods to reduce downstream
MAPK signaling have been investigated. Recently, targeting of the upstream regulator of KRAS activity, SHP2
has been brought to the forefront of the field. SHP2 is essential for the development of PDAC in mouse models,
despite mutant KRAS presence. However, while the role of SHP2 in PDAC has been largely attributed to its
regulation of the MAPK pathway, evidence in many other tissue types argue that SHP2 should be contributing
to tumor progression through other mechanisms – most notably, through regulation of intracellular calcium flux.
Our preliminary data shows that SHP2 interacts upstream of calcium flux with the enzyme phospholipase-c-
gamma-1 (PLCγ1). Recent literature has described the mechanism of this interaction as we have begun to define
the outcomes of disrupting the pairing and downstream calcium flux, providing evidence that uncouples the
canonically attributed role of SHP2 in PDAC from the MAPK pathway. Our probing of the metabolic functions of
SHP2 inhibited PDAC cells leads us to hypothesize that SHP2 and PLCγ1 interact to sustain calcium signaling
required for the activation of mitochondrial enzymes in the citric acid cycle. In this vein, we will take a two pronged
approach to investigating SHP2’s role in metabolism: first, by using the Agilent Seahorse Fuel-Flex testing we
can pinpoint the metabolic dependencies of SHP2 inhibited cells, and mechanisms of resistance to metabolic
stress; second, we will capture the steady state metabolite profile of PDAC cells in response to differential SHP2,
MEK, or PLCγ1 activity to take an untargeted approach to defining the metabolic implications of each protein’s
function individually and collectively. Additionally, we believe that the outcomes of this interaction are not limited
to changes in mitochondrial function. Therefore, we hypothesize that by comparing SHP2 inhibited and MEK
inhibited PDAC cells’ global changes to their phospho-proteome, we will be able to delineate the MAPK-
independent-functions of SHP2 as an oncogene in PDAC signaling. We expect the outcomes of this proposal to
highlight the importance of SHP2 in tumor progression/cancer cell signaling outside of the MAPK pathway, while
still appreciating its role in regulating KRAS activity. We believe that the conclusions of this study will yield a new
network of protein interactions to be investigated as targets in PDAC, eventually leading to development of
therapeutics for improved patient outcome.

Public health relevance
PROJECT NARRATIVE Greater than 90% of Pancreatic Ductal Adenocarcinoma (PDAC) cases harbor a mutation in KRAS that allows continuous, sustained activity. We’ve found that SHP2 is essential for PDAC development by playing a role in promoting KRAS signaling, but we’ve found it functions in other signaling pathways that can drive tumor progression, as well. Therefore, we propose that SHP2 acts in multiple ways to promote tumor growth, providing tumors resistance to treatments that block KRAS signaling alone.